Genetically Encoded Lipidation to Manipulate Structure, Assembly, and Phase Behavior of Proteins

Nearly one in five human proteins are post-translationally lipidated, and while the critical role of post-
translational modification in regulating different facets of cell biology (e.g., signaling, membrane localization,
etc.) has been well established, many mechanistic questions remain unanswered. These include the effects of
lipidation on the energetics, conformations, and function of lipidated proteins (LP) — and on human diseases.
Advancing our understanding of protein lipidation at the biophysical level and elucidating the sequence–
structure–function rules in various biological milieus, require study of the changes in protein structure and
conformation as the physicochemistry of lipid, lipidation site, and proteins are systematically modified.
However, such efforts have been stymied by the challenging and laborious methods to synthesize lipid-
modified proteins. To advance understanding of protein lipidation, my program will genetically engineer
prokaryotes to incorporate a diverse set of lipids into proteins, enabling the rapid generation of comprehensive
libraries of model LPs with broad physicochemical diversity. The overarching hypothesis of this program is that
the biophysical consequences of protein lipidation is governed by a “molecular syntax”, which is based on the
interplay between the physicochemistry of the lipid, protein, and the lipidation site that (de)stabilizes folding or
assembly of intermediates via (non)native interactions between lipid, protein sidechains, and the aqueous
milieu. To test this hypothesis, diverse and complementary biophysical and soft-matter characterization
techniques will be used to (1) study the tertiary structure and quaternary organization of model globular and
disordered LPs across three distinct structural hierarchies—single protein chains, lipid-driven supramolecular
assemblies, and liquid-liquid phase separation-driven higher-order assemblies (condensates); and (2) quantify
the contribution of these structures and the LP’s physicochemistry to encoded functional/material properties
such as biomolecular switching, viscoelasticity, and contact mechanics. By establishing platforms to engineer
sequence-defined LPs and revealing a rigorous, biophysically rooted molecular syntax underlying their
structure and energetics, this research program will substantially broaden the design space and functional
landscape of biomolecules beyond protein’s amino acid-based motifs. Ultimately, this program will enable a
better understanding of the role of LPs in diverse biological mechanisms in health and disease, and the
development of materials and therapeutics with complex structural and functional properties whose capabilities
rival natural biosystems for wide applications in nanomedicine and biotechnology.

Public health relevance
Despite broad interest in understanding the biological implications of protein lipidation, how the structure of appended lipids regulates the conformation and function of disease-related lipidated proteins remains unclear. To close this gap, this MIRA program will elucidate the biophysical rules governing assembly, aggregation, and function of physicochemically diverse libraries of lipidated proteins, prepared from operationally simple, high- yield biosynthetic routes. These biophysical insights will contribute to a mechanistic understanding of the role of lipidated proteins in health and disease and facilitate the application of lipid-modification in the development of next-generation drug carriers, biomaterials, and therapeutics.